Behavioral Resource, Analysis and Integrative Neuroscience (BRAIN) Core

PROJECT SUMMARY/ABSTRACT
BRAIN CORE
The Behavioral Resource, Analysis & Integrative Neuroscience (BRAIN) Core provides key technical and
research design support for all main and pilot projects associated with the DEARC. A primary goal of the
DEARC is to characterize and analyze the brain and behavioral adaptations that emerge as a result of ethanol
(EtOH) exposure at various developmental stages. The BRAIN Core plays several critical roles within the
Center: it provides expertise and training in breeding, EtOH exposure paradigms, behavioral assessments and
the evaluation of sex differences (Aim 1). Resources and expertise for the implementation of molecular and
genetic techniques for assessments of developmental EtOH effects are also provided by the BRAIN Core (Aim
2). For the evaluation of neuroanatomical changes associated with developmental EtOH exposure, the BRAIN
Core will maintain microscope systems and provide training for immunohistochemical approaches coupled with
rigorous quantitative analysis (Aim 3). The BRAIN Core provides access to consultation for advanced statistical
techniques for complex and unique data sets (Aim 4). It is the mission of the BRAIN Core to provide critical
methodological resources to all DEARC affiliated components by (1) supplementing scientific rigor; (2) training
research personnel and assisting PI’s in the authentication of key biological and chemical resources used in
experiments; (3) augmenting the strong collaborative foundation for data and resource sharing; and (4)
creating an environment that cultivates insight and approaches to deal with nascent findings and potential
synergisms across projects.